Bioinformatics Core

PROJECT ABSTRACT
The K-INBRE Bioinformatics Core promotes cutting edge research in Cell and Developmental Biology by
addressing requirements for computational resources within the K-INBRE Network, providing expertise to solve
complex problems in data analysis, and developing a statewide system to train the next generation of
researchers. Supported by advances in Next Generation Sequencing (NGS) technology, the Bioinformatics Core
will continue to focus on genomics, transcriptomics, and genome biology. The Director of the K-INBRE
Bioinformatics Core, S. Brown, KSU University Distinguished Professor in Biology, is an expert in genome
sequencing, mapping, and informatics. She is joined by Assistant Professor of Biostatistics D. Koestler, a
statistical genomicist, as Satellite Core Director at KUMC, and Associate Professor of Molecular Biosciences S.
Macdonald, a quantitative geneticist, as the Satellite Core Director at KU-L. Together, these Bioinformatics Core
directors leverage their expertise in Genomics, Genome Biology, Developmental Genetics, Quantitative
Genetics, and Biostatistics to provide research support, training opportunities, and educational curricula in
support of scientists using NGS approaches to address research problems in cell and developmental biology
across the K-INBRE network.
The Bioinformatics Core staff have assembled teams of bioinformaticians, biostatisticians, and computer
specialists to: 1) work with biomedical researchers in designing experiments, analyzing data, and interpreting
results that lead to publication and grant application; 2) collaborate with high performance computing centers at
KSU (Beocat) and KU-L (KU-CRC) to provide access to the cyberinfrastructure required to transfer, store,
analyze, and interpret large data sets; 3) develop pipelines and databases that foster collaboration,
multidisciplinary science, and clinical translation; 4) provide training opportunities in the form of workshops,
seminars, and student research scholarships that will facilitate practical application of these resources by K-
INBRE students, postdoctoral fellows, and faculty; and 5) develop course curricula to train the next generation
of biomedical researchers in genomics, bioinformatics, and biostatistics. Overall, the Bioinformatics Core has
had excellent progress and is proactive in developing a new pipeline of bioinformatics scholars in Kansas.